Peptide Amphiphiles to Augment Progentitor Cell Therapies

Program Director/Principal Investigator (Last, First, IVIiddle): LoSOrdO, DouglaS W. (LoSOrdO, PrOJOCt 1) Performance Site: Northwestern University 303 East Chicago Ave Tan7 14* floor Chicago IL, 60611 Northwestern University 303 East Superior Ave Lurie 11'^ floor Chicago IL, 60611 Senior/Key Personnel: Samuel I. Stupp, PhD (Co-Investigator) Board of Trustees Professor of Materials Science, Chemistry, and Medicine Director, Institute for BioNanotechnology in Medicine Other Significant Contributors: none Human Embrvonic Stem Cells: none PHS 398/2590 (Rev. 06/09) Page 89 Continuation Format Page Program Director/Principal Investigator (Last. First, IVIiddle): LosordO, Douglas W. (Losordo, Project 1) The name of the program director/principal investigator must be provided at the top of each printed page and each continuation page. RESEARCH GRANT TABLE OF CONTENTS Page Numbers Cover Page 88 Description, Project/